Collaborative Approach for Asian Americans, Native Hawaiians, and Pacific Islanders Research and Education (CARE) 2.0

Project Summary/Abstract of CARE 2.0
Despite being the fastest growing racial population in the United States, Asian American,
Native Hawaiian, and Pacific Islander (AANHPI) persons remain severely underrepresented in
research. For example, less than 3% of participants in the National Alzheimer's Coordinating
Center database are AANHPI individuals and even fewer are enrolled in clinical trials of
promising therapeutics. The Collaborative Approach for Research and Education (CARE)
registry (R24 AG063718) is a US multi-lingual registry built to improve AANHPI representation
in Alzheimer’s disease and related dementias (ADRD), aging, and caregiving research.
Launched in October 2020, CARE has enrolled 9,405 AANHPI adults (as of 10/2/22) including
55.9% with limited English proficiency and 80.9% with no prior research participation
experience. CARE has referred more than >5,500 participants to 27 studies that are in various
stages of recruitment and study completion. As a critical next step and guided by the NIA health
disparities framework, we propose CARE 2.0 to strategically expand the registry, advance the
science of recruitment and retention of AANHPI participants, and examine the factors
associated with research enrollment decisions among referred registry participants. Our specific
aims include: 1) Examine attitudes toward health research in a diverse cohort of 10,000 newly
recruited AANHPI adults in the US; 2) Elicit perspectives and recommendations from CARE
participants about registry retention, and develop, implement, and evaluate recommended
registry retention strategies. The Lightning Report Method will be used to conduct dynamic
qualitative data analysis and rapid synthesis of the findings to allow rapid comparative analyses
across groups and contexts to derive targeted strategies that are sensitive to the diverse needs
of retaining AANHPI participants; and 3) Optimize CARE registry participants’ inclusion in NIA-
funded and other aging studies and examine factors including study- and participant-level
factors associated with participation in research. These innovative aims will increase and test
the value of the CARE registry and inform the field more broadly on how best to increase
representation of AANHPI groups in research. CARE is well-positioned to complete these aims
and contribute to the growing science of recruitment and retention. This proposed application is
responsive to PAR-22-093 (Research on Current Topics in ADRD) and NOT-AG-21-033 (Notice
of Special Interest: Health Disparities and AD).

Public health relevance
Project Narrative of CARE 2.0 This project will implement CARE 2.0, an extension of the ongoing CARE (Collaborative Approach for Asian Americans, Native Hawaiians & Pacific Islanders (AANHPI) Research and Education) registry, launched in October 2020 to improve representation of AANHPI groups in Alzheimer’s Disease and Related Disorders (ADRD), aging, and caregiving research. As a critical next step, CARE 2.0 will 1) strategically expand the registry in the US with emphasis to increase enrollment of AANHPI groups underrepresented in CARE 1.0 and examine registry participants’ research attitudes in participation in health research; 2) examine and develop methods to improve registry retention; and 3) optimize CARE registry participants’ inclusion in ADRD, aging, and caregiving research and examine the factors associated with research enrollment decisions by registry participants. To our knowledge, CARE is the only US multi- lingual registry with a focus on supporting ADRD, aging, and caregiving related research for AANHPI populations and will be uniquely positioned to improve representation of AANHPI groups in research while also advancing the science of recruitment and retention.